Advancing rehabilitation of patellar tendon injuries using innovative wearable technology and quantitative magnetic resonance imaging techniques

ABSTRACT
My career goal is to optimize rehabilitation, improve treatment outcomes, and mitigate the debilitating long-term
consequences from lower extremity tendon injuries. In this study I propose to enhance the treatment for patellar
tendon injuries. The patellar tendon is a key structure for force transmission, mobility, and locomotion. The best
evidence-based treatment for tendon injuries involves tendon loading via exercise; however, establishing optimal
dosing remains a challenge. Clinical trials have prescribed exercises assuming external loads serve as
surrogates for tendon load, however, this assumption is not entirely accurate due to commonly observed
compensations at adjacent joints in patients with knee injuries. Thus, methods to directly measure tendon load
are needed. Shear Wave Tensiometry (SWT) is a clinically feasible, wearable technology that can directly
measure tendon load in-vivo. Neuromuscular Electrical Stimulation (NMES) during exercise is a promising
approach that may improve outcomes by augmenting tendon load, yet its direct effects on tendon load have not
been quantified due to lack of innovative technology to study the effects. Current methods for assessing recovery
from tendon injuries are also insufficient for accurately capturing effectiveness of treatments. Tendon pathology
observed at the macrostructural level does not always relate with symptoms, and improvements in symptoms
tend to precede changes to tendon macrostructure. Diffusion Tensor Imaging (DTI), a magnetic resonance
imaging based method to measure tendon microstructure in-vivo, offers potential to better study tendon
pathophysiology and treatment response. This project aims to capture tendon adaptations at the microstructural
level using DTI in response to a rehabilitation program focused on tendon loading quantified via SWT and
enhanced by NMES. Two patellar tendon injuries will be studied: patellar tendinopathy and bone-patellar tendon-
bone autograft harvest for anterior cruciate ligament reconstruction. Aim 1 will establish DTI methodology to
quantify patellar tendon microstructure and the relationship with knee function in patients with patellar tendon
injuries. Aim 2 will quantify patellar tendon loads using SWT during key rehabilitation exercises with and without
NMES in patients with patellar tendon injuries and in a healthy cohort. We will rank tendon loads during exercises
and compare the rankings between patients with patellar tendon injuries and healthy controls. The ability of
NMES to augment tendon load will also be studied. Lastly, Aim 3 will develop and determine the preliminary
efficacy of a SWT-informed rehabilitation protocol and quantify the treatment effects using DTI in patients with
patellar tendinopathy. In a 12-week clinical trial, we will assess improvements in patient symptoms and function,
and if DTI can capture acute microstructural changes in response to treatment. Through the K99/R00 award, I
will gain the qualifications and preliminary data necessary to independently lead randomized controlled trials.
This research proposal is expected to broadly impact tendon injury rehabilitation, potentially improving treatment
for multiple tendons and pathologies.

Public health relevance
PROJECT NARRATIVE This K99/R00 proposal aims to investigate tendon microstructural adaptations in response to a personalized rehabilitation program incorporating individualized exercise-based tendon loading enhanced by neuromuscular electrical stimulation in patients with patellar tendon injuries. Innovative technologies such as diffusion tensor imaging (DTI) for non-invasive MRI-based quantification of tendon microstructure, and shear wave tensiometry (SWT) for measuring dynamic tendon load during rehabilitation, will be used. The findings are expected to optimize the current gold standard exercise-based rehabilitation strategies for tendon injuries and enhance our understanding of tendon structural responses to treatment.